Macrophage/Microglia dysfunction in age-related auditory nerve degeneration

PROJECT SUMMARY
Age-related hearing loss (ARHL) is a major public health concern, as the United States population continues to
age. Although hearing devices are available, they do not address the root causes of ARHL which include auditory
nerve (AN) degeneration, including demyelination. There is an urgent need for novel treatment approaches that
prevent or slow age-related AN degeneration. Recently, studies show that AN demyelination contributes to
hearing impairments, however the exact mechanism of demyelination in the aging auditory system remains
unclear. Myelin maintenance and repair is a life-long process, but the efficiency of myelin repair declines with
age. The pattern recognition receptor Dectin-1 (Clec7a) has been implicated in demyelination and
neurodegeneration. Preliminary data show: 1) increased macrophages/microglia in regions of demyelination in
the aged human AN, 2) evidence of microglial phagocytosis of myelin in the human AN, and 3) upregulation of
Dectin-1 expressing macrophages/microglia in the aged mouse AN. These data suggest that Dectin-1 may
contribute to age-related macrophage/microglia dysfunction, demyelination, and AN degeneration. Although
macrophages/microglia in the auditory system are well-documented, their contributions to AN degeneration are
unclear. Based on previous studies and preliminary data, I propose that aging increases Dectin-1 expressing
macrophages/microglia, creating a proinflammatory immune cell population that exacerbates demyelination and
AN degeneration. Aim 1 will test the hypothesis that Dectin-1 expressing macrophages/microglia are
proinflammatory and associated with AN demyelination in aged mice and human donors. In this aim, I will define
the age-dependent changes in Dectin-1 expressing macrophages/microglia in AN demyelination using a
combination of quantitative immunohistochemistry, 3D high-resolution imaging, and single nucleus RNA-
sequencing. This study will evaluate inflammatory infiltration of Dectin-1 expressing macrophages/microglia in
demyelinated regions of the AN in young and old CBA/CaJ mice and validate findings in human tissue. Dectin-1
expressing macrophages/microglia are predicted to express more proinflammatory markers in aged ANs in
regions of demyelination. Aim 2 will test the hypothesis that reducing Dectin-1 expression will prevent myelin
degeneration of the AN by decreasing microglia activation and limiting inflammation, thus preserving AN function.
This study will use a global Dectin-1 knock-out mouse model to directly evaluate the effect of Dectin-1 depletion
on proinflammatory macrophage/microglia activation and AN degeneration. Mice will undergo threshold and
suprathreshold auditory physiology (e.g. auditory nerve responses and measures of phase locking values (PLV)
to assess AN function). Dectin-1 KO mice are predicted to show less age-related AN demyelination, stronger
PLV, and reduced proinflammatory activation. These studies will advance our understanding of
macrophages/microglia in AN pathology and potentially reveal a new biomarker of AN degeneration.

Public health relevance
PROJECT NARRATIVE Auditory nerve loss, including disruption of myelin structures, is a major contributor to the pathology of age- related hearing loss. The proposed research will investigate age-related changes in Dectin-1 dependent immune cell activation and inflammation in auditory nerve loss and myelin structure disruption in both mice and humans. The results may reveal a new immune-dependent component contributing to auditory pathology as well as identify potential biomarkers of age-related hearing loss.